Synaptic Function within Mature Central Pain Networks after Neonatal Injury

Project Summary/Abstract
Infants admitted to a neonatal intensive care unit (NICU) regularly experience tissue damage as part of
their essential medical care. Preclinical studies have shown that neonatal injury causes a prolonged
reorganization of synaptic circuits in the mouse spinal superficial dorsal horn (SDH), enhances neuroimmune
signaling in the adult spinal cord, and exacerbates chronic pain following repeat injury later in life via a process
called ‘neonatal priming’. Astrocytes are strong candidates to mediate neonatal priming since they are known
to tightly regulate synaptogenesis, synaptic pruning, neuronal excitability and neuroinflammation in the CNS,
and contribute to the pathogenesis of chronic pain in adults. Unfortunately, nothing is currently known about
how neonatal tissue injury shapes the function of immature astrocytes in the developing SDH. It is also
unclear if astrocytes catalyze the long-term alterations in synaptic transmission and neuroimmune signaling
within the adult SDH following early life injury, and are essential to the subsequent priming of developing pain
circuits. The objective of this application is to elucidate the plasticity of developing spinal astrocytes after early
life injury and to determine whether astrocytes govern both the persistent functional changes in the mature
SDH and neonatal priming. The central hypothesis is that neonatal tissue damage persistently alters the
morphology and function of astrocytes in the developing SDH, leading to a disruption in the balance of synaptic
excitation vs. inhibition, enhanced capacity for pro-inflammatory signaling and exacerbated chronic pain. The
rationale of the proposed research is that by yielding novel insight into the cell types governing the lifelong
sensitization of the SDH network following neonatal injury, these studies will lay a conceptual foundation for
new interventional strategies to minimize the adverse long-term effects of early life trauma on the maturation of
pain pathways in the CNS. Guided by strong preliminary data, the central hypothesis will be tested by
pursuing the following specific aims: (1) Determine the influence of early life tissue injury on developing spinal
astrocytes; (2) Identify the role of astrocytes in the rewiring of dorsal horn circuits after neonatal injury; and (3)
Elucidate the contribution of spinal astrocytes to neonatal priming. These aims will be accomplished by using
a multidisciplinary experimental approach that includes intersectional mouse genetics, confocal microscopy,
calcium imaging, ex vivo electrophysiology and behavioral assays of pain sensitivity. The proposed work is
innovative because it will be the first to reveal the plasticity of astrocytes within developing spinal nociceptive
circuits under normal or pathological conditions and to identify their role in neonatal priming. The expected
outcome of these investigations will be the identification of astrocytes as a common orchestrator of the myriad
persistent effects of early life injury on nociceptive processing in the CNS. Therefore, the proposed research is
significant because it would implicate a discrete cellular population that could ultimately be targeted to disrupt
the emerging link between neonatal pain and a greater propensity to experience chronic pain as adults.

Public health relevance
Project Narrative The expected outcomes of the proposed research will have a positive impact on public health by yielding novel insight into the cellular and molecular mechanisms by which neonatal tissue damage can sensitize spinal nociceptive circuits throughout life. Such information would aid in the design of new interventional strategies to disrupt the emerging link between pain during early life and a greater propensity to experience chronic pain during adulthood.